HEPATITIS C IN DRUG USERS--EFFECTS OF HIV AND OTHER FACTORS

The purpose of this investigation is to asses virologic, environmental and other host factors that affect the progression of chronic HCV infection. The Outpatient Clinical Research Center at Johns Hopkins has been utilized to evaluate patients by history and physical examination in follow-up after undergoing liver biopsy. From 1211/96 through l 1/30/97, 102 liver biopsies were performed with all of these patients seen in follow-up in the Outpatient GCRC.